Characterizing noncoding GWAS variants in acute lymphoblastic leukemia treatment outcome

PROJECT SUMMARY
Acute lymphoblastic leukemia (ALL) is the most prevalent childhood cancer, and although overall survival rates
of ALL have substantially improved, resistance to antileukemic agents remains a major clinical problem.
Antileukemic drug resistance is predictive of poor disease outcome and is commonly observed in ALL patients
that have relapsed, who have a low overall survival rate of only 40%. The mechanisms that cause ALL relapse
and drug resistance remain poorly understood. To address how inherited genomic variability contributes to these
mechanisms, genome wide association studies (GWASs) have identified DNA sequence variation associated
with ALL treatment outcome. However, since these variants are noncoding in nature, their connection to gene
function, ALL biology and antileukemic drug resistance has been difficult to establish. Moreover, given that
hundreds of variants are typically in strong linkage disequilibrium with the associated variant, pinpointing causal
variants at GWAS loci has been challenging. To address these challenges, we have generated functional
genomic maps of the ALL genome, including the precise locations of noncoding regulatory elements in >40 ALL
samples. Through rigorous open chromatin-fine mapping using our ALL genome maps, and by integrating our
results with drug resistance phenotypes from primary ALL cells obtained from patients at St. Jude (SJ), we
identified 3229 variants at 125 GWAS loci associated with ALL treatment outcome that are predicted to have an
impact on gene regulation, leukemic cell biology and antileukemic drug resistance. Using these fine-mapped
variants, we propose an integrative strategy for identifying candidate causal variants associated with ALL
treatment outcome, and a rational experimental system for functionally linking these variants and their target
genes to antileukemic drug resistance. In Aim 1, we will perform massively parallel reporter assays (MPRAs) on
>3200 fine-mapped variants to assess their gene regulatory activities and to identify allele-specific differences
in activity. In Aim 2, we will employ a polygenomic strategy by integrating our MPRA results with diverse genomic
datasets to prioritize and rank fine-mapped variants by their likelihood of being causal. For this effort, we will
capitalize on the unique and rich resources available at SJ, including extensive genomic characterizations and
drug resistance phenotypes from large ALL patient cohorts, as well as ongoing genomic characterizations for all
new and/or relapsed patients. We will functionally validate the role of the top 20 ranked candidate causal variants
on antileukemic drug resistance using CRISPR technology and chemotherapeutic drug viability assays in human
ALL cell lines. We will also identify GWAS target genes and functionally assess their role in antileukemic drug
resistance in human ALL cell lines and in patient-derived xenograft mouse models of pediatric ALL. Collectively,
our proposal will uncover novel genomic mechanisms of antileukemic drug resistance. Ultimately, these data
can inform approaches to circumvent resistance in the clinic, and be used to improve initial treatment, as well as
guide therapy for relapsed disease through precision medicine and more personalized treatment regimens.

Public health relevance
PROJECT NARRATIVE This research proposal will employ an integrative strategy to identify and functionally characterize genetic determinants involved in acute lymphoblastic leukemia (ALL) treatment outcome. ALL is the most prevalent childhood cancer, and despite cure rates exceeding 85% with contemporary treatment, relapsed ALL is the 5th most common pediatric cancer with a low overall survival of only 40%, and is commonly characterized by a resistance to antileukemic drugs, which remains the primary cause of treatment failure in ALL. The results generated by this proposal will uncover novel genomic mechanisms of chemotherapeutic drug resistance, and these data can be further used to improve treatment strategies for newly diagnosed and for relapsed ALL by aiding in the development of novel therapeutics that bypass or mitigate drug resistance mechanisms, and/or in the optimization of existing treatment regimens.